Advancing Conformance with the Voluntary National Retail Food Regulatory Program Standards

Advancing Conformance with the FDA Retail Program Standards in Yellowstone County Project Summary The purpose of this project is to reduce the occurrence of foodborne illness in Yellowstone County. The purpose will be achieved by utilizing the Voluntary National Retail Food Regulatory Program Standards (Program Standards) as an improvement tool to identify risk factors for foodborne illness and to improve the effectiveness of inspections and intervention strategies to reduce the occurrence of risk factors. The project objectives are: (1) to measure the occurrence of foodborne illness risk factors in retail food establishments, (2) to evaluate trends over a period of time to determine progress, (3) to evaluate and improve intervention strategies designed to reduce the occurrence, (4) to improve uniformity of inspection practices, (5) to sustain improvement and achieve greater conformance with the FDA Voluntary National Retail Regulatory Program Standards and to share tools and strategies with other agencies. The first three objectives will be achieved by conducting a second risk factor study. Data will be analyzed to track changes in the occurrence of risk factors and evaluate the effectiveness of interventions implemented after the baseline study. New interventions will be developed and implemented following the second study. Interventions may include food safety training, educational campaigns, and process changes. Food Safety Inspection Officers (FSIOs) will be trained on intervention strategies to assure effective and uniform implementation. The fourth objective, to improve uniformity of inspection practices, will be addressed by implementing a peer review inspection program modeled after that used in King County Washington. Results will guide staff training to reduce inconsistencies. In addition, FSIOs will continue to be re-standardized every three years. The final objective is to sustain improvement and achieve greater conformance with the FDA Voluntary National Retail Regulatory Program Standards. A self-assessment completed in May 2017 indicated that four of the nine Standards were fully met. This proposed project work will result in meeting the remaining standards. Strategies and tools will be shared via Food Shield and at the Pacific Region FDA Retail Food Seminar. By striving for greater conformance with the Retail Program Standards, we can reduce the occurrence of the risk factors for foodborne illness in our community, strengthen our relationships with the retail food industry, and use our resources more efficiently and effectively.

Public health relevance
Advancing Conformance with the FDA Retail Program Standards in Yellowstone County Project Narrative The mission of RiverStone Health is “to improve life, health and safety” and we strive to accomplish that by providing HELP – Health, Education, Leadership and Protection. According to the Centers for Disease Control and Prevention (CDC), 48 million people get sick, 128,000 are hospitalized, and 3,000 die from foodborne diseases each year in the United States. Applying the Voluntary National Retail Food Regulatory Program Standards as an improvement tool, supports our mission by helping us to identify risk factors for foodborne illness and improve the effectiveness of inspections and intervention strategies which will ultimately reduce the occurrence of foodborne illness in our community.